Chronic and acute molecular programs enabling working memory

Abstract
Working memory is a form of short-term memory that is required for most daily activities, from
reading, to driving, to conversing. As such, deficits in working memory are highly disabling and
are prominent in learning disability, ADHD, and in Schizophrenia where it is the most important
predictor of long-term prognosis. Currently, no treatments exist to improve working memory.
Pioneering studies in humans and animal models established a central role for the prefrontal
cortex in enabling working memory. Emerging work from our lab and others demonstrate
important complimentary roles of thalamus in shaping thalamo-cortical synchrony underlying
working memory. An important next step is to understand the molecular programs in thalamus
that sustain such long-range thalamo-cortical neural activity on the time-scale of seconds to tens
of seconds during working memory. This will provide new mechanisms for how memory is enabled
on short time-scales, and also offer therapeutic targets for reversing working memory deficits.
Towards this, we recently identified a novel orphan receptor that functions in thalamus as a potent
modifier of short-term memory. In this proposal, we will delineate the chronic (steady-state)
transcriptional and gene-regulatory programs downstream of Gpr12 that promote and maintain
working memory. We will also identify acute (activity-dependent) recruitment of Gpr12
downstream signaling during working memory behavior. Finally, we will link Gpr12 molecular
function with its role in maintaining sustained and synchronized thalamo-cortical activity during
working memory. The overarching goal of this work is to provide new insight into molecular
programs in thalamus that shape thalamo-cortical activity underlying working memory. Such
discoveries will inform how our brains enable us to maintain task-relevant information on short
time-scales. More broadly, this study will help work towards novel therapeutic strategies for
reversing working memory deficits associated with schizophrenia, and related mental illnesses.

Public health relevance
Project Narrative We previously identified a novel orphan receptor, Gpr12, as a potent modifier of short-term memory. This study reveals the interacting partners of Gpr12, and the resulting long-term molecular programs that prime and sustain neural activity during short-term memory. More broadly, it helps identify therapeutic targets for reversing short-term memory deficits associated with learning disability, aging, and mental illness.